Advancing VR-based attentional bias as a biomarker for tobacco use disorder

PROJECT SUMMARY
There are few effective treatment options for smoking cessation. The identification and validation of reliable
biomarkers for tobacco use disorder has the potential to greatly facilitate treatment development and improve
clinical outcomes. Attentional bias, a behavioral correlate and potential biomarker of addiction, is consistently
observed in nicotine users and is related to the risk of subsequent relapse following smoking cessation. Our
group has developed and tested a novel virtual reality (VR) nicotine cue exposure paradigm with promising
preliminary results, including obtaining large nicotine-related attentional bias effect sizes. Thus, the goal of the
proposed project is to validate the attentional bias neurophysiological marker derived from the VR Nicotine Cue
Exposure paradigm (VR-AB) as a biomarker of tobacco use disorder and investigate its potential as a predictive
marker and candidate surrogate endpoint for use in the development of novel pharmacologic interventions for
smoking cessation.
To achieve the goals of this project, 200 daily tobacco cigarette users will be assessed on the VR Nicotine Cue
Exposure paradigm then pseudo-randomized (matched on age and sex) to receive varenicline or placebo (n per
group=100). Following eight days of titration, participants will be assessed again on the VR Nicotine Cue
Exposure paradigm at target dose of varenicline (1 mg twice daily). They will then be followed via mobile
assessments for eight days on the target dose to assess short-term nicotine use behaviors. Varenicline will be
used as a pharmacological challenge to validate the VR-AB marker given this medication’s proven ability to
attenuate nicotine craving/cue salience and reinforcement.
In accordance with NIDA’s Notice of Special Interest on Biomarker and Biotypes of Drug Addiction (NOT-DA-
20-012) and the FDA’s Biomarkers, EndpointS, and other Tools (BEST) resources, the broad aims of the
proposed project are to: (1) validate the reliability of the VR attentional bias (VR-AB) marker and estimate the
VR-AB effect size as moderated by varenicline, (2) evaluate VR-AB as a predictive biomarker for response to
varenicline, and (3) evaluate VR-AB as a candidate surrogate endpoint by assessing the predictive validity of
the VR-AB biomarker on short-term nicotine use behaviors as moderated by varenicline.

Public health relevance
PROJECT NARRATIVE Despite tobacco use being the leading preventable cause of death in the United States, over 51 million U.S. adults continue to use tobacco products. This research proposal could substantially advance treatment development for tobacco use disorders and addictions broadly by evaluating the validity of the VR-AB biomarker for use as a predictive and/or surrogate endpoint in clinical smoking cessation trials. The validation of reliable biomarkers of addiction such as attentional bias would greatly benefit treatment development by providing earlier identification of treatment efficacy, thus shortening trial lengths and costs considerably, and by the identification of subpopulations, or biotypes, that may be more likely to respond to a given treatment.